Cell Processing and Vector Production

PROJECT SUMMARY: Cell Processing and Vector Production (CPVP) Shared Resource
The Cell Processing and Vector Production (CPVP) Shared Resource provides manufacturing of therapeutic
grade cellular therapy products and viral vector for use in early phase clinical trials. These must be prepared
according to current Good Manufacturing Practices (GMP) as mandated by the Food and Drug Administration.
This Shared Resource provides the infrastructure and environment to prepare, test, and release these
products for use. It consists of a state-of-the-art facility with 22 manufacturing clean rooms and support
facilities (quality control and flow cytometry laboratories, material management facilities etc.), and highly
experienced manufacturing and quality control and assurance staff. This DLDCCC Resource will work with
investigators to develop clinical scale manufacturing procedures, and release test specifications, testing
procedures, quality assurance oversight, and regulatory assistance to assist in IND submissions. The resource
has, therefore, facilitated the transition of cellular and gene therapy products from the basic science
laboratories in the DLDCCC into early-phase clinical trials. The CPVP currently supports more than 50 clinical
trials (21 actively accruing, 18 in follow-up, and 11 in stages of translation to investigational new drug
applications [INDs]) held by DLDCCC investigators and does so at a much-reduced cost compared to
commercial manufacturing and testing entities.